REACH Center Developmental Core

PROJECT SUMMARY - DEVELOPMENTAL CORE
The Developmental Core aims to provide pilot funding, networking, and educational and training
opportunities to develop a multidisciplinary, community-engaged climate and health research
workforce. The Core integrates and cross-pollinates environmental research with public health research
by distributing $80,000 annually through a REACH Pilot Awards Program and sparking multi-disciplinary
collaborations through a Student Research Fellowship program. For the Pilot Awards, the Core will
ensure a strong applicant pool, soliciting innovative and significant proposals, implementing a
competitive application review process, and engaging pilot awardees in Center activities. The Student
Research Fellowships will engage students from all three academic institutional partners to work as a
collaborative cohort on a project that addresses a non-academic partner need and leverages big data to
advance health-protective solutions. The Developmental Core will also provide educational and
networking activities that catalyze multidisciplinary and cross-institutional collaboration in relevant
research. The Core will offer educational activities, including a journal club, workshops to promote
improved team science, and trainings on geospatial datasets to build an informed climate and health
research workforce. The Core will also implement cross-institutional networking activities including
Annual Research Days, research seminars, a lunch series, scientific working groups focusing on shared
interests among Center investigators, and expanding clinical engagement and clinical research. It will
foster a strong existing interdisciplinary network and emerging collaborations in research grants linking
several Center investigators. Finally, the Developmental Core will ensure that climate and health
research is responsive to topics arising from government and community stakeholders, collaborating
closely with the Community Engagement Core. This will be accomplished by engaging government and
community partners in Pilot Awards and by co-sponsoring workshops with the Community Engagement
Core to facilitate improved knowledge-to-action and community engaged research. The Developmental
Core will deliver innovative approaches throughout the research design and implementation phases by
prioritizing community engagement and solution-oriented goals throughout all of its research and
educational activities. The ultimate goal is for REACH research projects to be co-generated by
community and policy stakeholders in partnership with Center investigators, thereby ensuring that the
research and its results are actionable and lead towards solutions to protect health.